A Longitudinal Study of Physical Activity and Function in Older Veterans with Serious Mental Illness

Serious mental illness (SMI), which includes the mental health conditions of schizophrenia, schizoaffective
disorder, bipolar disorder, and major depressive disorder, disproportionately affects the Veteran population and
is a leading cause of disability in the United States. Not only do Veterans with SMI experience mental health
symptoms but they also have high rates of chronic medical conditions that further reduce quality of life. The
physical burden of SMI compounds with age such that older Veterans with SMI have an even higher number of
chronic health conditions, are at increased risk for falls, are more likely to be admitted to a nursing home and
engage in physical activity less often than their same age peers without SMI. As a result, the multimorbidity faced
by older Veterans with SMI significantly reduces the independence and functioning of this population.
Multicomponent exercise is an established modality to improve the health of older Veterans and is particularly
effective for increasing all facets of physical function (cardio/endurance, strength, mobility, balance). Physical
function, which is known to worsen during the aging process, particularly with increased sedentary time, is a
critical intervention target for older Veterans given its association with independence, quality of life, falls, and
survival. Despite the compromised health of older Veterans with SMI and the established benefits of exercise for
older Veterans, there is a lack of research on physical function and exercise for this population. This Career
Development Award (CDA-1) will fill this gap by exploring function and physical activity in older Veterans with
SMI who participated in Gerofit, a national VA-supported clinical exercise program. The Gerofit clinical database
contains performance-based physical function data on balance, mobility, lower/upper body strength, and
endurance/cardio as well as self-report data on health-related quality of life and social support collected at
enrollment, three months, six months, and 12 months. These data have been collected from 1,698 older Veterans
from 11 (out of 17) national VA sites from 2007-2019, of which 14% (n=236) have SMI. The Gerofit clinical
database and SMI diagnostic information obtained from the VA electronic health record will be used to examine
three aims: (1) characterize the baseline function of older Veterans with SMI in Gerofit across all functional
domains (balance, mobility, strength, endurance/cardio) by comparing them to age- and gender-based
population norms and to older Veterans without SMI in Gerofit, (2) evaluate one-year changes in all domains of
physical function of older Veterans with SMI in Gerofit and compare the magnitude of change to that of older
Veterans without SMI in Gerofit, and (3) examine six- and 12-month Gerofit program retention in older Veterans
with SMI by comparing retention rates by SMI status (SMI vs. non-SMI) and examining baseline predictors of
retention in older Veterans with SMI including age, race, ethnicity, health-related quality of life, social support,
and physical function. Dr. Browne’s training plan will facilitate completion of these aims and the development of
new skills (e.g., assessment and interpretation of function, advanced analytic techniques) and content knowledge
(e.g., intersection of aging and mental health, health promotion of older Veterans with SMI). She will participate
in didactic and professional development activities throughout the award period to support achievement of these
training goals and receive mentorship from a team of experts in aging, SMI, exercise, physical function, and
Veteran health (Drs. Katherine Hall, Miriam Morey, Eric Elbogen, Kim Mueser). This CDA-1 will also generate
necessary pilot data for a subsequent CDA-2 application, which will be a natural extension of this work. This
CDA-1 award is an essential first step to advance Dr. Browne’s long-term career goals of developing behavioral
interventions to improve the quality of life and reduce the burden of multimorbidity in older Veterans with SMI
and integrating health promotion into routine clinical practice.

Public health relevance
Older Veterans with serious mental illness (SMI; schizophrenia, schizoaffective disorder, bipolar disorder, major depressive disorder) have high rates of chronic medical conditions, engage in low levels of physical activity, and are at heightened risk for falls and early nursing home admission. In turn, this subgroup of Veterans has reduced independence and quality of life. This CDA-1 proposal will explore physical function, which includes cardio/endurance, strength, mobility, and balance, in older Veterans with SMI. This work will also be the first to study whether older Veterans with SMI participate in an established VA-supported clinical exercise program and whether they experience functional benefits. This project will promote greater understanding of the functional domains most compromised in this population and offer the first glimpse as to whether exercise improves function in this group of Veterans. This work will inform efforts to improve the quality of life and health of older Veterans with SMI.